Identification of endophenotypes associated with Alzheimer’s disease progression in Hispanic population

Abstract
Dementia is caused by a constellation of age-associated neurodegenerative diseases collectively termed
Alzheimer’s disease and related dementias (ADRD). ADRDs impair individuals' ablity to correctly function and
constitutes a major worldwide public health problem, with no effective treatments available. ADRDs affect people
of all ethnicities, but Hispanics are especially affected by it. Hispanics have 1.5-fold higher risk of developing
ADRD than non-Hispanic whites. ADRDs are complex phenotypes and their diagnosis often requires invasive
measures. Therefore, identifying reliable noninvasive early ADRD biomarkers is a key topic to provide better
early diagnosis and guide patient’s treatment. Toward this goal, this project aims to identify novel non-invasive
endophenotypes using transcriptomic profiling in an existing cohort of Hispanics from the Maracaibo Aging Study
(MAS) living in Maracaibo, Venezuela. The MAS, begun in 1998, has surveyed longitudinally genetic,
environmental, and socioeconomic elements that may contribute to ADRD prevalence. The MAS project
currently includes ~5000 elderly individuals (aged ≥55 yr) and a subset of 415 genetically related participants
that have been extensively phenotyped, including complete MRI brain imaging and comprehensive cognitive
assessment with a high ADRD prevalence (6.8%). Using a family-based design, we calculate that genetic factors
account for 67% of the variability in disease risk. To identify novel ADRD and cognitive decline endophenotypes,
we will construct a RNASeq library for 1000 MAS participants, and apply our ERV (Endophenotype Ranking
Value) method. We will divided MAS participants into two equal subsets of 500 each for discovery and replication
sets respectively coming from Santa Rosa and Santa Lucia communities in Venezuela. The discovery subset
will include 122 ADRD cases defined by DSM-IVR criteria and, more importantly, a set of 243 1st- to 5th-degree
biological relatives who are not currently suffering from dementia. We will contrast them with a set of 135
unaffected individuals (lacking known relatives with ADRD) to identify gene expression endophenotypes.
Differences between these groups can only occur due to genetic correlation between ADRD risk and an
endophenotype as identified by the ERV method taking into account covariates such as age, age at onset, sex
and APOE locus status. Endophenotypes detected in the discovery set will be confirmed as biomarkers in a set
of 250 ADRD cases and 250 unaffected controls using a linear mixed model and later annotated by means of a
scientific literature review. We tested our approach's validity using existing data from our Genetics of Brain
Structure Study where we identified strong associations between known the expression of candidate genes’ and
dementia risk. We will apply the ERV method to the MAS gene expression data and predict that it will perform
even better since the MAS population manifests higher ADRD prevalence. This project will serve as a stepping
stone to further characterization of ADRD predisposition in Hispanics and our approach may identify potentially
novel candidate genes that confer or protect against ADRD risk in this population. The expected results of this
scientific proposal will be the necessary seeds for future scientific proposals that will further extend our findings.

Public health relevance
Narrative Alzheimer’s disease and related dementias (ADRDs) confer reduced cognitive function on millions of individuals worldwide causing affected elderly people to lose functional capacity and their independence. The absence of reliable non-invasive biomarkers currently limits the definition of early risk for ADRD and, therefore, we will use a novel approach to identify gene-expression based biomarkers associated with increased ADRD risk using a well characterized sample of elderly Hispanic individuals from the Maracaibo Aging Study. The new non-invasive biomarkers will improve our current understanding about Alzheimer’s disease progression and will aid the early identification of potential ADRD patients.